Using Neuroimaging to Enhance Veteran Suicide Risk Detection and Prevention

Background: This application is for a five-year Career Development Award (CDA) to support my transition to
becoming an independently funded VA clinical science and suicide prevention researcher.
Career Plan: To successfully achieve my career goal of understanding why people die by suicide to enhance
risk identification and prevent suicide among high-risk Veterans, I need further mentored training in two
advanced clinical research methods, including neuroimaging and technology-based ecological momentary
assessment (EMA), and biostatistics. My training objectives are to develop expertise in these three areas
through formal coursework, seminars, clinical training, and mentorship from Kelvin Lim, MD (primary mentor;
Minneapolis VA Health Care System, MVAHCS), Paul Thuras, PhD (MVAHCS), and Evan Kleiman, PhD
(Rutgers University).
Research Plan: This CDA examines brain regions associated with suicide capability among high-risk Veterans
who are discharging from inpatient care. Suicide capability contributes to the transition from suicidal thinking to
suicide attempts and distinguishes people who attempt suicide from those who think about it but do not act. As
such, suicide capability is a valuable suicide prevention target. During inpatient care, Veterans will complete
baseline assessments. After discharge, Veterans will complete suicide capability tasks while undergoing MRI
scanning and daily EMA surveys for one month.
Specific Aims: 1) Characterize the within-day associations of suicide capability and suicidal thoughts; 2)
Compare activation in specific brain regions and suicide capability task responses when completing suicide
capability tasks between depressed suicide attempters and depressed controls; and (3) Investigate the
associations between brain activation during suicide capability tasks and self-reported suicide capability.
Significance and Innovation: Suicide rates are especially high among Veterans during the transition from
inpatient to outpatient care, pointing to the need for improved suicide risk detection and prevention strategies
for Veterans after discharge. The proposed research investigates suicide capability, a promising suicide
prevention target given its role in the transition from suicidal thinking to suicide attempts. Neuroimaging and
technology-based EMA methods will be leveraged to advance our understanding of suicide capability and
facilitate future proposals evaluating biological interventions targeting suicide capability that may impede the
progression from suicidal thinking to suicide attempts. This work is responsive to calls by the VA and
national/international organizations to optimize suicide prevention strategies for Veterans during high-risk
transition periods.

Public health relevance
I am applying for five years of mentored research and training. The proposed project and training plan address critical gaps in suicide prevention for Veterans. Suicide capability is a key factor in the transition from suicidal thinking to suicide attempts and a promising target for suicide prevention, yet little is known about the neural basis of suicide capability and how suicide capability changes over time. The proposed study will advance our understanding of the neural and dynamic aspects of suicide capability among high-risk Veterans during acute suicide risk periods. We expect that the results will have important implications for suicide prevention by revealing suicide-specific brain regions that may be targeted by biological interventions to reduce suicide capability and suicide risk. I will obtain mentored training in neuroimaging, technology-based ecological momentary assessments, and advanced statistical methods. This award supports my long-term career goal of improving suicide prevention strategies to reduce suicide rates among Veterans.